TRITIUM NMR ANALYSIS VT279 &VT286: CARDIOVASCULAR &PULMONARY DISEASE: SODIUM

The subject compounds were tritium labelled under contract at Vitrax, Inc. As a small business, Vitrax, Inc. lacks the resources to conduct tritium NMR analyses of labelled products. Such NMR studies serve to confirm the site and level of tritium labelling, as a final step in the quality assurance for customers. VT279 is a new candidate sodium channel blocker. VT286 is a new drug candidate under evaluation for cardiovascular and pulmonary disease applications. Tritium and proton NMR analyses only. User Details: Experiment Details: User Number: 1703 NMR City, State: Placentia, CA 1 day Funding Source: Industry 2 compounds Charge: $458.62 Program Income: $458.62